The 10th International Symposium on Middle Ear Mechanics in Research and Otology (MEMRO 2025)

Project summary/abstract
We are seeking partial support through this proposal to cover the expenses for the 10th International Meeting of the
Middle Ear Mechanics in Research and Otology (MEMRO) 2025 conference, scheduled for June 2025 at the KU Leuven,
in Belgium. In alignment with the objectives established at the inaugural MEMRO meeting in 1996, the purpose of this
triennial event is to bring together experts in middle ear science and engineering with clinical otologists to facilitate an
exchange of knowledge and ideas between these typically independent groups. Previous MEMRO meetings in Shanghai
(2018) and Denmark (2015) each attracted approximately 200 participants from over 20 countries. The 2022 meeting
had slightly fewer participants since scientists from many countries, including China, Japan, Australia, and others, that
would normally attend the MEMRO meetings were still precluded from travel due to COVID restrictions. We expect the
10th edition to have a higher attendance.
The 2025 meeting aims to continue promoting the free exchange of ideas between basic and clinical scientists and to
establish a framework for innovative collaborative efforts to enhance our understanding of middle ear function,
dysfunction, and repair. A primary goal of this meeting is to increase the diversity of attendees, with a particular focus
on engaging otology residents and faculty by hosting a hands-on workshop on methods and technologies the day prior
to the formal conference. Also many efforts have been made to increase the presence of underrepresented countries.
We have promoted the conference on multiple occasions on other world conferences. We have representatives from all
continents in the scientific committee. The 2025 MEMRO meeting is being organized by KU Leuven, Belgium's largest
and highest-ranked university and is an excellent center for education, research and Innovation. Leuven is a vibrant city
only 15 minutes by train from Brussels Airport allowing easy travel, and is rich in art, history, and architecture, offering
attendees ample opportunities to experience this dynamic international city.

Public health relevance
Project Narrative Repairing middle ear pathologies is a frequent surgical procedure performed by ear surgeons, highlighting the critical need to enhance our understanding of middle ear mechanics in both normal and pathological conditions. In addition, over the past years, we have seen a rising interest in the option to implant a microphone in order to optimize outcomes with hearing implants, also for the inner ear (with more than 1 million users worldwide). The upcoming conference will appeal to basic scientists, otolaryngologists, engineers, as well as residents and students. Collaboration among these diverse groups of researchers and practitioners, as demonstrated in previous meetings, will contribute to advancements in the diagnosis and treatment of middle ear diseases and related pathologies such as implantable microphones for cochlear implants.